Conformational Change in Molecular Biology

[unreadable] DESCRIPTION (provided by applicant): The long term goal of molecular approaches to biology is to describe living systems in terms of the laws of chemistry and physics. Theoretical methods can serve to complement experimental studies to obtain an understanding of the molecular machines that play a vital role in the function of living cells. The two molecular motors Fi-ATPase and DNA polymerase I (pol I) will be investigated. The rotatory nanomotor, FoFi-ATP synthase, of which Fi-ATPase is the globular catalytic moiety, is responsible for the synthesis of ATP, the energy currency of cells. The model for this motor developed in the previous grant period raises specific questions, which will be investigated. How is the rotation of the y-subunit induced by the conformational changes of the catalytic p-subunits during the ATP hydrolysis cycle? What conformations of the catalytic p-subunits are involved in catalysis? For DNA pol I, the translocation step in DNA replication, which follows incorporation of a new base into the primer strand, will be elucidated. The pathway from the pre-translocation to the post-translocation state will be determined and utilized to obtain the atomic details of the key steps involved. The nature of "short-term memory" (i.e., the effect of mismatches in the synthesized DNA, away from the active site, on translocation) will be studied. For both motors, classical dynamical methods (in particular, the new restricted perturbation targeted molecular dynamics algorithm) will be used to determine the nature of the pathways and quantum mechanical/molecular simulations will be employed to study the reactions involved. The results will increase our understanding of the diseases caused by malfunction of these motors. Macro-cyclic inhibitors of mitochondrial FoFi-ATPase will be developed as a possible approach to cancer therapy. A knowledge of the mechanism of two molecular motors, FoFi-ATPase, which makes ATP, and DNA polymerase I, which accurately copies DNA, is essential for a description of cellular function. We will study how these motors work and employ the results to find inhibitors for ATP synthesis in the mitochondria, a suggested treatment of cancer, and to interpret the effect of replication errors in DNA synthesis by polymerases. [unreadable] [unreadable] [unreadable]